Defining Ocular Monkey Pox Pathogenic Mechanisms

PROJECT SUMMARY:
Mpox virus (MPXV), formerly Monkeypox virus is a zoonotic pathogen that spreads rapidly through human-
human transmission via respiratory droplets and direct contact, causing painful rashes and systemic issues. It
also causes moderate to severe ophthalmic manifestations, most commonly ocular surface complications such
as keratitis, conjunctivitis, and blepharitis, with poorly understood pathogenic processes. The 2022 MPXV strain
(Clade IIb) has caused approximately 100,000 infections and 207 deaths to date, indicating its evolution towards
more rapid human-to-human transmission compared to previous strains (Clade I and Clade IIa). Our preliminary
data show that the 2022 MPXV strain induces an inflammatory response and increases cell death in human
corneal epithelial cells. Similarly, MPXV infection in mouse eyes causes periocular pock lesions, ptosis, and
corneal opacity, indicating keratitis. Infected mouse corneas exhibit increased infiltration of CD45+ immune cells.
Moreover, MPXV infection decreases levels of the antiviral STING protein that senses cytoplasmic DNA through
cGAS and triggers type I interferon responses to restrict virus replication. Genomic analysis of the 2022 MPXV
strain indicates the acquisition of new mutations across the viral genome. Two genes have been identified among
the 21 Clade IIb viral gene variants that degrade antiviral STING proteins. Based on these data, we hypothesize
that MPXV continuously evolves to better circumvent the host innate immune system and cause ocular Mpox.
The overall goal of this study is to define both viral and host determinants of MPXV in causing ocular pathology
and to identify potential therapeutic targets for antiviral therapy. This will be accomplished through three specific
aims. Aim 1 is designed to determine the in vitro susceptibility of ocular cell types and host inflammatory
responses to MPXV. In addition, using a library of kinase inhibitors and innate immune agonists, we will dissect
cellular signaling and innate immune pathways during MPXV infection of ocular cells. In Aim 2, we will
characterize the MPXV viral genes antagonizing antiviral STING pathway activation. Recombinant MPXV mutant
viruses lacking the ability to evade cGAS-STING detection will be evaluated for their ability to replicate and
modulate innate responses in ocular cells. In Aim 3, we will study the pathogenesis of ocular Mpox caused by
MPXV clades in mouse models and test the efficacy of two novel antiviral compounds (kinase inhibitors).
Collectively, this proposed study would yield novel insights into the pathogenesis of ocular Mpox and potentially
lead to the identification of newer therapeutic targets.

Public health relevance
PROJECT NARRATIVE The 2022 strain of monkeypox (mpox) virus (MPXV) that was responsible for the recent outbreak in the United States caused painful rashes on extremities, face, and genitals, along with systemic issues. MPXV infection is also associated with various mild to severe ophthalmic conditions collectively termed, "ocular mpox," including vision-threatening conditions like corneal scars and keratitis. Our research will utilize ocular cell cultures and animal models to investigate host and viral factors contributing to ocular mpox and aims to identify potential novel therapeutic targets.